Empowering dentists to reduce opioid prescriptions to young people

ABSTRACT
Dentists are the leading prescriber of opioids to adolescents and young adults (AYAs), even though opioid use
after tooth extraction is not associated with improved pain control or satisfaction. In AYAs, an opioid prescription
after a dental procedure increases the risk of opioid misuse, use disorder, and overdose. The long-term goal of
this project is to develop a framework to reduce opioid prescriptions to AYAs for treatment of acute dental pain.
The objective of this proposal is to establish the effectiveness of a multicomponent intervention at reducing
dental opioid prescription rates after tooth extraction in AYAs. Our central hypothesis is that a multicomponent
intervention is required to produce significant reductions in post-extraction opioid prescriptions to AYAs. The
rationale underlying this proposal is that a multicomponent intervention will address provider knowledge,
motivation, and choice architecture better than a single-component strategy; will engage and educate patients;
and will provide a physical item for distribution instead of an opioid prescription. We will test this hypothesis by
pursuing four specific aims: in the UG3 period, 1) complete requisite preliminary work to test a new approach
to manage acute pain following dental treatment, and in the UH3 period: 1) establish effectiveness of a novel
educational and drug-dispensing approach using academic detailing, patient education, and blister-packaged
non-opioid analgesics to reduce opioid prescriptions following tooth extraction among AYAs; 2) examine key
implementation outcomes of the intervention designed to modify dental professional decision-making behaviors;
and 3) assess patient-reported pain management, analgesic use, and drug disposal after tooth extraction. To
accomplish these aims, we propose a stepped wedge cluster randomized trial of community and academic clinics
across Kentucky using an innovative intervention of one-on-one provider education plus provider distribution of
patient education materials and standardized blister packs containing acetaminophen and ibuprofen. This study
will be conducted across at least 10 of the largest oral surgery practices in Kentucky, enrolling at least 27
providers expected to perform tooth extractions on over 40,000 AYAs. We will assess effectiveness using a
primary endpoint of the patient-level binary indicator of being prescribed an opioid. Secondary endpoints
include intervention acceptability, appropriateness, feasibility, and fidelity (UH3 aim 2); and patient-reported pain,
pain interference, analgesic use, and drug disposal (UH3 aim 3). The proposed research is significant because
it will provide a framework for wide-scale implementation of interventions to modify dental decision-making
behaviors towards evidence-based recommendations for acute pain management, resulting in a reduction in
opioid prescription rates after tooth extraction. The expected outcome is a framework to implement effective
interventions to reduce dental opioid prescribing to AYAs. The results will have a positive impact immediately
because they will limit unnecessary opioid exposure, and long-term because they will help dentistry build a
framework for reducing the impact of substance use disorders across the United States.

Public health relevance
NARRATIVE Dentists are a leading prescriber of opioids to young people, which have a particularly high risk of misusing opioids, developing a substance use disorder, or overdosing. Efforts to reduce dental opioid prescribing commonly use single interventions, do not specifically target young people, and are performed primarily in academic settings. This large study will test whether a bundled intervention of academic detailing, patient education, and non-opioid blister packs for distribution reduces opioid prescriptions to adolescents and young adults after tooth extraction.